Deciphering The Role of RNA Modifications In Maternal Mrna Clearance

Abstract
Maternal RNA clearance is an essential process that occurs in the absence of transcription in all sexually
reproducing species examined. Stored maternal transcripts sustain early embryonic development prior to
activation of the embryonic genome. Perturbations of maternal mRNA degradation can either halt or irreparably
alter the maternal-to-zygotic transition, leading to early embryonic demise. Oocytes are unique cells in which
translation and RNA clearance are coupled, in the absence of new transcription. Maternal mRNA is eliminated
via translationally coupled mRNA degradation, a process that includes recruitment of mRNA to the ribosome,
shortening of the poly(A) tail, decapping, and degradation by both 5′ and 3′ exonucleases. Mechanisms that
regulate translationally coupled mRNA degradation are poorly understood. Recent studies have established
RNA modifications as regulators of maternal mRNA clearance. Our previous work established that inosine
RNA modifications within the coding region of mRNA can impact maternal mRNA stability through a translation
mechanism. Here, I describe two research directions I will pursue in the next 5 years that address fundamental
questions about the role of RNA modifications in maternal mRNA clearance. The first direction will investigate
the relationship between inosine mRNA modifications in translation. The second direction will focus on
identifying the relationship between inosine RNA modifications and other RNA modifications, and how this
combined “RNA modification code” can regulate RNA stability and translation during maternal mRNA
clearance. We will use innovative molecular analyses, novel RNA-sequencing approaches, proteomics, in vivo
imaging, and combined single molecular/single oocyte assays to test how inosine impacts translation, alters
the occurrence of amino acid substitutions, and how this facilitates maternal mRNA clearance. In addition, I will
catalog the “RNA modification code” on whole, individual transcripts in oocytes to determine the relationship
between multiple RNA modifications and maternal mRNA clearance. While these studies will significantly
advance the understanding of RNA processing in oocytes, the discovered principles will also apply to other
cells. In fact, inosine RNA modifications were first discovered in oocytes (Xenopus laevis), and this novel
discovery led to a change in the entire way we view RNA processing mechanisms. The utility of the oocytes as
a model will enable the impact of RNA modifications on the fate of the RNA to be amplified, and will advance
our appreciation of the biological roles RNA modifications have within cells, organs, and organisms. These
studies will provide a powerful framework of understanding that will build the research focus of the Brachova
lab for the future, eventually leading to an understanding of the relationship between RNA modifications and
embryo genome activation.

Public health relevance
NARRATIVE This project delves into the mechanisms of RNA metabolism, utilizing the oocyte as a model to elucidate how RNA modifications like inosine govern translation processes. The proposed studies will 1) scrutinize the regulatory impact of inosine and other RNA modifications on translation, and 2) investigate how these modifications intertwine with translation to expedite mRNA clearance. Through these mechanistic explorations, the endeavor aims to broaden our foundational comprehension of RNA modifications in post-transcriptional gene expression regulation, insights that are transferable to diverse biological systems, enriching our understanding in broad areas of human health and disease.